The Cell Envelope of the Multi-Drug Resistant Pathogen Acinetobacter baumannii

ABSTRACT
The increasing rise in antibiotic resistance and the diminished discovery of new antimicrobials threatens global
healthcare. Of particular concern are Gram-negative pathogens, as these organisms are intrinsically resistant
to multiple classes of antibiotics and the discovery of novel drugs targeting these bacteria has remained
challenging. The innate resistance of these organisms is provided primarily by their outer membrane (OM), a
defining feature of Gram negatives that encapsulates their peptidoglycan layer. Unlike the inner membrane
(IM) that is composed solely of glycerophospholipids (GPLs), the OM is asymmetrical with GPLs found in the
inner leaflet and lipopolysaccharide (LPS) localized to the outer leaflet. This unique membrane organization
affords protection from large polar molecules, as well as lipophilic compounds, creating an impervious barrier.
Remarkably, the high-priority Gram-negative pathogen Acinetobacter baumannii can completely inactivate LPS
biosynthesis as an alternative mechanism of resistance to the “last-resort” polymyxin antibiotics. The primary
objective of this application is to investigate the mechanisms required for maintenance of the cell envelope of
A. baumannii, regardless of LPS status. While the benefit of an asymmetric OM relative to a GPL bilayer is
apparent due to the impermeable barrier it provides, the lack of LPS essentiality in A. baumannii can be used
as a tool to explore novel mechanisms of OM stability in both the presence and absence of LPS. For Aim 1,
we will investigate the role of surface lipoproteins that are induced during envelope stress and that are
prominent during LPS-deficiency. We will also investigate how these proteins are transported across the OM.
Aim 2 focuses on the characterization of two glycosyltransferases required for the tandem transfer of sugars
during LPS synthesis, a unique mechanism in the assembly of a bacterial glycoconjugate. Finally, in Aim 3, we
will characterize a novel OM cardiolipin synthase and how it impacts OM integrity. An OM cardiolipin synthase
challenges current dogma that dictates all major GPLs are synthesized at the cytoplasmic face of the IM.
Completion of the Aims will provide novel insights into cell envelope biogenesis and promote the development
of novel therapeutics targeting Gram-negative pathogens.

Public health relevance
PROJECT NARRATIVE Much like armor, Gram-negative bacteria (e.g., Escherichia coli) have a unique outer surface that prevents the use of many antibiotics making infections caused by these organisms extremely difficult to treat. This proposal will help determine the molecular machinery used by the Gram-negative bacterium Acinetobacter baumannii, an extensively drug-resistant bacterium causing devastating disease, to assemble its outer surface.